CENTRALIZED CHEMOPREVENTIVE AGENT REPOSITORY AND DRUG CHEMISTRY SUPPORT

Establishment of a centralized source of agents for use in preclinical and clinical studies by the Division of Cancer Prevention(DCP) of the National Cancer Institute (NCI) and to perform certain agent-related pharmaceutical characterization, formulation, and documentation activities.